Determining the role of circadian rhythms in Chlamydia associated tubal infertility

One of the manifestations of Chlamydial pathogenesis in women is tubal factor infertility (TFI). The molecular
mechanism underpinning the pathologic changes that cause TFI is poorly understood. We have reported that
the time of day of infection influences chlamydia infectivity and pathogenesis. Results from our lab show that
when circadian rhythms were disrupted using a Jet lag model, chlamydia-infected mice had increased infectivity
and pathology. Our work has demonstrated that miRNAs and genes associated with circadian rhythms are
differentially expressed during chlamydia infection. Our premise in this study hypothesizes that circadian rhythms
have a role in controlling/regulating chlamydial pathogenesis, leading to infertility. The central goal of this project
is to understand the role of circadian rhythms on chlamydial pathogenesis through these aims (1) Investigate the
association of host circadian rhythms with chlamydial pathogenesis. We hypothesize that circadian control of
chlamydial pathogenesis is essential in determining disease outcomes. We will determine the role and
involvement of clock genes Bmal1, Per2, and Cry1 on chlamydial pathogenesis using commercially available
Bmal1KO, Per2KO, and Cry1KO mice. (2) Define the circadian control of pathways involved in chlamydial
pathogenesis. We hypothesize that the intrinsic disposition of the genital tract to pathogeneic changes will
depend on what genes/proteins are activated or inhibited by clock genes. We will also determine genes that are
undergoing cycling at different states of chlamydia infection. We will test this hypothesis using C. muridarum
infected WT, Bmal1KO, Per2KO, and Cry1KO mice. This study gives us a basis to predict the level of severity
of pathogenesis after chlamydia infection and identify new underlying mechanisms involved in chlamydia
pathogenesis. By accomplishing the outcomes of the specific aims, we predict that the knowledge gained will
positively impact women's reproductive health.

Public health relevance
Complications arising from Chlamydia infection are of public health importance. This study involves understanding the novel mechanisms associated with circadian rhythms and Chlamydia- induced pathogenesis that may lead to tubal factor infertility. This proposal is relevant to NIH's mission, it will identify new disease biomarkers, pathways and elucidate the molecular mechanisms underpinning pathogenesis caused by chlamydia infection, thus impacting women's reproductive health.